Molecular mechanisms of anthrax toxin unfolding and translocation

PROJECT SUMMARY
To function, a protein must be correctly localized in the cell, especially in ones that are internally
compartmentalized by membrane bilayers. Proteinaceous, membrane-embedded transporters, called
translocase channels, can traffic proteins across membranes by a process known as transmembrane protein
translocation. Translocase channels also play key functional roles in microbial pathogenesis, because a host
cell’s lipid bilayer membrane functions as a formidable, first line of defense, isolating the pathogen from its
cytosol. The bacterium, Bacillus anthracis, for example, secretes a three-protein toxin, called anthrax toxin,
which is composed of protective antigen (PA), lethal factor (LF), and edema factor (EF). PA assembles into a
translocase channel, forming a narrow passageway across the host cell’s endosomal membrane bilayer. The
channel, however, is so narrow that LF and EF traverse it as unfolded polypeptide chains potentially with some
transient helical structure. Once inside the target cell’s cytosol, LF and EF refold and then catalyze reactions
that disrupt the cell’s normal physiology.
Studies of protein unfolding and transmembrane translocation probe exciting biophysical questions,
which apply broadly to the studies of soluble molecular motors, which unfold, disassemble, and degrade
proteins. How is a thermodynamically stable substrate protein unfolded in the cell? What structural features in
the translocase channel determine the complex energy landscape that guides a chemically-complex, unfolded
chain through the narrow confines of the channel? The biophysical chemistry of transmembrane protein
translocation, nonetheless, has been challenging to characterize, and the three-dimensional structures of many
translocase channels are unknown. Bacterial toxins, like anthrax toxin, are particularly well-suited for these
studies, because they carry their own translocase-channel machinery, which is able to spontaneously insert
into lipid bilayer membranes. We will couple the spectroscopic tools used to study how proteins fold and unfold
with single-channel planar lipid bilayer electrophysiology. We are ultimately interested in how these systems
function as proton-gradient driven ratchets, how the unfoldase active sites or polypeptide clamps stabilize
unfolding intermediates, how these clamp sites gate and ungate. Our overall goal is to define the molecular
mechanism of force transduction and ratchet-based unfolding and translocation.
Relevance: Knowledge of protein translocation mechanisms are of practical importance not only to
developing novel methods to neutralize the toxin but also to advancing technologies, which exploit toxins as
delivery vehicles for heterologous antigens and cytotoxins into immune and cancer cells.

Public health relevance
PROJECT NARRATIVE Anthrax toxin is a three-protein toxin secreted by Bacillus anthracis, the causative agent of anthrax and a priority CDC select agent. A biophysical understanding of the toxin’s transmembrane translocation mechanism is the immediate goal of these studies, where elucidating this process will be critical to understanding how the cytotoxic components of the toxin can gain access into mammalian host cells. The longer-term goal is to translate this knowledge into new applications, namely the development of a novel nanopore biosensor and a versatile peptide drug delivery system.